Helping Veterans Navigate Dual Pharmacy Benefits

Background: Nearly 30% of Veterans with diabetes dually use Medicare Part D and VA to fill
their antidiabetic medications, and dual users have poorer glycemic control and poorer
medication adherence than Veterans who fill only through VA. Yet few resources exist to help
Veterans understand and navigate between these dual pharmacy benefits.
Significance/Impact: The goal of this research is to understand how Veterans are choosing
between VA and Part D, identify knowledge gaps, and rigorously develop and test an
intervention that will educate and optimize Veteran choice on prescription coverage.
Innovation: This research is innovative because it: i) uses a stated-preference research
method, called a discrete choice experiment, to quantify Veteran preferences when choosing
which pharmacy benefit through which to fill their antidiabetic medications and ii) rigorously
develops the first Veteran-facing decision aid that helps improve Veteran decision-making about
where to fill their medication. By applying a Veteran-centered intervention focused on access to
care and health care value to an aging population with a costly and prevalent condition, this
proposal aligns with strategic goals for HSR&D, PBM, and VA in general.
Specific Aims: The specific aims of the CDA-2 proposal are: 1) Identify medication acquisition
challenges and informational needs that Part D-enrolled Veterans have when filling antidiabetic
medications through VA or Medicare Part D; 2) Estimate how Veteran preferences around
aspects such as prescription coverage, travel time, wait time, medication copay, and chance of
adverse events influence where Part D-enrolled Veterans choose to fill antidiabetic medications;
3) Develop and assess feasibility and acceptability of a decision aid that helps Part D-enrolled
Veterans comprehend VA and Medicare Part D prescription benefits to optimize choice on
where to fill medications; and 4) Evaluate how dual use of VA and Part D to fill antidiabetic
medications affects medication expenditures for Veterans, Medicare, and VA.
Methodology: The proposed research consists of four projects, all focused on Part D-enrolled
Veterans using antidiabetic medications. Project 1 is a qualitative study to identify knowledge
gaps and other medication acquisition barriers that Veterans experience when filling
medications through Part D versus VA. Project 1 will comprise of 24 interviews with Part D-
enrolled Veterans with type 2 diabetes, and 12 interviews with caregivers. Project 2 consists of
a discrete choice experiment study that estimates how Veterans trade off between different
aspects such as prescription coverage, travel time, wait time, medication copay, and chance of
adverse events when they decide where to fill their medications. Project 3 will involve the
development and assessment of feasibility and acceptability of a decision aid based on findings
from Aims 1 and 2. Project 4 will encompass a retrospective cohort study, using VA Corporate
Data Warehouse medical records linked to Medicare claims data, to study the impact of dual
use of pharmacy benefit on costs to Veterans, Medicare, and VA.
Implementation/Next Steps: Two IIRs will be submitted to support: i) an expanded secondary
data analysis that informs future implementation of the decision aid and ii) a hybrid type I
effectiveness-implementation trial assessing the impact of the decision aid on Veteran
satisfaction; medication supply, switching, and adherence; glycemic control; and costs to the
Veteran and VA.

Public health relevance
PROJECT NARRATIVE Nearly 30% of Veterans with diabetes dually use Medicare Part D and VA to fill their antidiabetic medications. Dual users are more likely to have poorer medication adherence and poorer glycemic control than Veterans who obtain all of their antidiabetic medications through VA. Despite this prevalent and costly problem, there is a lack of resources to help Veterans understand and navigate between dual pharmacy benefits. This CDA addresses this gap by identifying Veteran informational needs and preferences when filling medications, and then developing a decision aid that helps Part D-enrolled Veterans navigate dual pharmacy benefits. This CDA aligns with the VA goal that Veterans choose VA for easy access, greater choices, and clear information to make informed decisions.